CCR Artificial Intelligence Resource

Current preclinical projects include: Automated Tumor Detection in preclinical images (collaboration with Dr. Mike Green from Molecular Imaging Branch, NCI, NIH) Automated tumor burden assessment on digital pathology in preclinical lung cancer models (collaboration with Dr. Chen Zhao from Thoracic and GI Malignancies Branch, NCI, NIH) Clinical projects Quantitation/classification of pediatric ovarian follicles (collaboration with Dr. Veronica Gomez-Lobo from Pediatric Adolescent Gynecology, National Institute of Child Health and Human Development, NIH) Automated Segmentation, Classification, and Growth Rate Tracking of hereditary renal cell carcinomas (RCC) (collaboration with Dr. Ashkan Malayeri from Department of Radiology and Imaging Sciences and Marston Linehan, NCI, Canine and Human Osteosarcoma subtyping and prognosis estimation (collaboration with Dr. Amy Leblanc)